Postdoctoral training in health services research

SUMMARY
This application requests five years of support for a postdoctoral training program in health services research
at the University of Pennsylvania (Penn). The overall goal of this program is to develop investigators who are
trained to conduct high-impact and rigorous health services research as independent investigators with the
goal of improving the quality, safety, efficiency, and equity of health care organization, financing, and delivery.
The program leverages Penn's immense resources dedicated to producing high-quality and high-impact health
services research including top-tier educational programs, outstanding mentoring, a robust research
infrastructure, and a strong institutional commitment to health services research. Addressing
the
complex
challenges
disciplines.
facing the nation's health care system requires input from diverse perspectives and
Thus, our program is designed for postdoctoral fellows (or postdocs), both physicians with clinical
backgrounds who are seeking to become clinician-researchers by acquiring thorough training in health
services research and PhD-trained economists who are seeking to gain skills applying their substantive
knowledge and research methods to the field of health care delivery. Our proposed program not only develops
the competencies for both of the trainee groups, but also, by linking clinician-researchers with PhD-trained
postdocs in the collaborative and rigorous training environment of health services research at Penn, we aim to
develop leaders who can build diverse and inclusive teams that combine disciplinary and institutional expertise.
This T32 will be led from Penn's Perelman School of Medicine (which houses one of the training program's key
educational curricula—the Master of Science in Health Policy Research (MSHP)) and will work in close
collaboration with LDI (which runs the second key training program—the LDI postdoc in health services
research). Perelman and LDI have a long and robust history of successful collaborations and, supported by
this environment, will also draw on expertise and mentoring from the Wharton School and the School of
Nursing. Together these entities are well suited to provide high-quality training to both clinician-researchers
and PhD-trained economists seeking to become independent and influential health services researchers. Thus,
the proposed program capitalizes on Penn's unique strengths in fostering health services research across
schools and disciplines by drawing on the expertise across the University.

Public health relevance
NARRATIVE Addressing the complex challenges facing the nation's health care system requires input from diverse perspectives and disciplines. This program is designed for postdoctoral fellows, both physicians with clinical backgrounds who are seeking to become clinician-researchers by acquiring thorough training in health services research and PhD-trained economists who are seeking to gain skills applying their substantive knowledge and research methods to the field of health care delivery. We aim to train future leaders in health services research—leaders who can address the current shortcomings of our health care delivery system and work towards making health care organization and delivery higher quality, safer, more efficient, and equitable and, ultimately, improve patient outcomes.